CELLULAR ALTERATION INDUCED BY ROUS SARCOMA VIRUS

The basic objective of this research is the elucidation of the mechanism of neoplastic transformation of cells. Special emphasis will be placed on the biochemical analysis of the process of transformation in cells infected with avian sarcoma viruses. The studies will include the determination of subcellular localization of oncogene products, the identification of target host protein(s) whose phosphorylation is critical for cell transformation, and the characterization of changes in the expression of normal cellular genes in the process of transformation. Analysis of the structure and functions of cellular and viral oncogenes and the conditions required for the conversion of the former to the latter will be continued. The basis for tissue specific transformation by some oncogenic viruses will be explored.